LEADERSHIP AND ADMINISTRATION

The purpose of this core is to provide the leadership and administrative support for the overall Program Project. Even though all of the Project and Core Leaders are members of the Brigham and Women's Hospital Renal Division, substantial effort will be needed to direct this Program Project and this will be provided by Dr. Curhan (also the overall PI for the Program Project). The administrative support will ensure maximal productivity during the funding period and will also guarantee close coordination and communication among the investigators and with the Advisory Committee. The Project Leaders will meet formally at least monthly to discuss scientific and administrative issues related to the Program Project. We will also meet formally with our Advisory Committee on an annual basis and with individual members of the Advisory Committee as needed during the year. Because of the substantial leadership and administrative experience of the Core Leader, the intimate involvement with the ongoing Nurses' Health Study I, Nurses' Health Study II and Health Professionals Follow-up Study, and the already existing close interactions among all the Project Leaders, this Program Project can be implemented efficiently, smoothly and successfully with the resources requested in the Administrative Core.